Vocabulary Encoding and Retention in Autism via Social Cognition (VERAS)

PROJECT SUMMARY
More than 2% of the population – 5.5 million adults – have Autism Spectrum Disorder (ASD), with the challenges
that stem from it, including theory of mind (ToM) and language impairments, extending across the lifespan. While
ToM difficulties – challenges in computing perspectives of others – are a hallmark of ASD, language impairments,
including in vocabulary, are present in over half the population. As vocabulary size correlates with vocational
independence, mental health, and quality of life, any barrier to vocabulary growth can pose as a significant
inhibitor to an autistic individual’s long-term well-being. Common word learning scenarios that mandate ToM
skills to resolve reference ambiguities are one such likely barrier, both in terms of the initial mapping and long-
term retention, and targeting or circumventing the ToM mechanisms inhibiting this a powerful route for
intervention. However, little is understood about the role that ToM plays in novel word mapping and retention in
autistic individuals, and the relationship between the ToM and memory networks during word learning has not
been characterized in any population. This behavioral and neurological paucity keeps us from identifying a link
between ToM skills and word learning in scenarios that should invoke them; such a link would be evidence that
interventions that focus on alternate vocabulary acquisition routes would address current weaknesses and
strengthening the ToM network would expand access to vocabulary learning scenarios in daily life rather than
only during an intervention itself. Thus, this study will focus on autistic and neurotypical adults with the goal of
accomplishing two aims. Aim 1 is to investigate word learning behavior and underlying neural mechanisms
in adults with autism. Here, functional magnetic imaging (fMRI) will characterize the role of the ToM network
and its connections to the memory network during initial mapping, immediate retrieval, and delayed retention of
novel words via pragmatic inference, which requires ToM and inferential resolution, lexical inference, which
requires inferential resolution but minimal ToM, and direct mapping, which requires minimal ToM or inferential
resolution, in autistic vs neurotypical adults. Aim 2 is to determine the preferred word learning context for
autistic individuals. Here, we will examine accuracy and reaction time during all three of contexts of Aim 1 for
mapping, retrieval, and retention. Finally, we will examine the relationship between the neural underpinnings
and the preferred word learning contexts of Aim 1 & 2. Vocabulary acquisition is the only language skill to
remain malleable across the lifespan; as such, interventions that target the mechanisms that support it provide
opportunities for increased vocabulary expansion in both autistic children and adults, and through this, increased
independence, opportunities, and quality of life. This fellowship take place at Northeastern University in Boston,
a hub of neuroimaging, language, and autism research, with goals of deepening fMRI expertise, learning
community-engaged research practices, and expanding interdisciplinary technical and communication skills.

Public health relevance
PROJECT NARRATIVE Over half of all autistic individuals demonstrate clinical levels of language impairment, including in vocabulary. Vocabulary skills correlate highly with vocational independence, mental health, and quality of life for autistic individuals – especially adults – and are the sole linguistic area to remain flexible across the lifespan. By studying how theory of mind difficulties in autistic individuals may be inhibiting vocabulary growth and determining the degree to which the underlying compensatory routes or alternative contexts may be leveraged in intervention, we will open the door to further linguistic interventions that can improve vocabulary – and thus language – outcomes even into adulthood and, through this, increase lifelong success.